Designing Effective Health Education for Patients Seeking Unregulated Stem Cell Interventions

Project Summary/Abstract
There are over 1,000 clinics in the U.S. marketing scientifically unsubstantiated stem cell interventions (SCIs)
outside federal regulation and oversight. One major risk to patients from unregulated SCIs is the harm of being
misinformed. This has led tens of thousands of patients to take an unregulated SCI resulting in physical,
financial, and emotional harm. Our aging population with chronic diseases is the main target of stem cell
commercials. They represent a unique group of health consumers who have exhausted conventional medical
options, have a desire to control their healthcare, and are actively seeking information on the internet for non-
conventional treatments. Several studies have shown that clinics aggressively market inaccurate or false
information to patients where SCIs are conveyed as beneficial, cutting-edge, and safe and effective. To date, it
is unclear what sources of health information patients consider credible or how patients differentiate between
opposing messages such as an advertisement versus a warning. The overall goal of this line of research is to
advance informed decision-making by this new group of health consumers searching alternative options for
chronic conditions. The primary purpose of this study is to explore patients’ knowledge and beliefs regarding
unregulated SCIs, their views on the credibility of online health information, and their perceptions on the
credibility and persuasiveness of online advertisements and warning messages. We will apply the results of
this formative research, informed by theories of health behavior and behavior change, to develop novel
messages to inoculate patients from misinformation or correct misconceptions about unregulated SCIs along
with providing evidence-based information about stem cell procedures. Our three specific aims are to
characterize patient knowledge, beliefs, online information seeking habits, and social networks when
considering unregulated SCIs (Aim 1); explore patients’ perceptions of source credibility (expert versus a
person like me) and persuasiveness of video and text-based advertisements and warnings about SCIs (Aim 2);
and develop and pre-test a pilot communication intervention to inoculate patients from misinformation and
correct misconceptions about unregulated SCIs (Aim 3). We will use qualitative research methods to address
all three aims and recruit potential participants from a unique database of patients who have called into a
regenerative consultation service to find out more about SCIs for their condition. Our work is particularly
innovative as it combines theories of health behavior and social psychology with patient perception data to
inform the design of communication interventions to combat misinformation. Upon completing this exploratory
research, we will be able to craft online messages that are salient and credible to address the unmet
informational needs of this group of health consumers and help address the global health problem of
unregulated stem cell and regenerative interventions.

Public health relevance
Project Narrative Over 1,000 clinics throughout the U.S. provide unregulated stem cell procedures to patients for a host of chronic diseases which have resulted in physical, economic and emotional injuries, including the harm from being misinformed about the effectiveness of stem cell procedures. Patients who seek information online about stem cells should be given evidence-based information, but no one knows what sources patients find credible, believable and persuasive, or how they consider opposing messages. This study will engage a cohort of patients who are avid information seekers about stem cells to assess their beliefs, online information sources and their credibility, and views on the credibility and persuasiveness of advertisements and warning messages available on the internet; we will use this data along with health behavior theories to develop communication messages aimed at inoculating patients against misinformation, correcting misconceptions, and providing evidence-based information about stem cell procedures.